9/10 Electrophysiology of Alcohol in Extended Amygdala

This is a competitive U01 renewal application under the Integrative Neuroscience Initiative on Alcoholism-
Neuroimmune (INIA-N) Consortium (Notice# RFA-AA-20-11/12/13). It is designed to integrate multidisciplinary
research projects based on the genomic, cellular, and behavioral neuroadaptations related to excessive alcohol
consumption. The overall premise is that excessive alcohol consumption produces changes and adaptations in
immune-related pathways that promote and sustain drinking. Mounting evidence indicates that immune-related
pathways, including cytokines, are critical to regulating neuronal functions in addiction-related brain regions that
underly the excessive drinking and behavioral phenotype associated with Alcohol Use Disorder (AUD). Notably,
transcriptomic, and functional results point to interleukin-6 (IL-6) signaling as a strong candidate to test our
central hypothesis that cytokines are integral to the neuroadaptations occurring in GABAergic and glutamatergic
synapses and play a critical role in excessive drinking and anxiety-like behaviors associated with ethanol
dependence and withdrawal. Specifically, we hypothesize that chronic ethanol-induced activation of IL-6
signaling is a major mediator of the central amygdala (CeA) and medial prefrontal cortex (mPFC) synaptic
changes that contribute to the escalation of drinking and the associated negative affect. We anticipate that
chronic ethanol will produce sex-, brain region- and cell type-specific IL-6 functional changes that subsequently
contribute to ethanol dependence-associated behavioral phenotypes and persist (or be exacerbated) with
ethanol withdrawal. We will study the IL-6 pathway and its positive and negative regulators (including SOCS3
and IL-10) to unveil potential therapeutic targets to alleviate ethanol-induced inflammation and ameliorate
alcohol-related behaviors. In Aim 1 and 2, to induce ethanol dependence, we will use the chronic intermittent
ethanol–two-bottle choice (CIE-2BC) paradigm in both male and female mice. We will apply behavioral,
biochemical, and electrophysiological approaches to characterize dysregulation of the IL-6 signaling pathways
in alcohol-drinking animals. Aim 3 will investigate the behavioral and electrophysiological effects of ethanol-
induced neuroimmune responses on physiological functions across species (rodents and rhesus macaques) and
cellular and molecular mechanisms of the candidate drugs/neuroimmune signaling that are identified by other
INIA-N projects. Thus, we anticipate that our studies will identify cellular mechanisms and neuroimmune targets
that contribute to excessive alcohol drinking. Furthermore, our INIA collaborations will promote replicability and
translational aspects by testing our key targets in multiple species using multiple complementary approaches to
bridge alcohol basic research with the human condition.
The key personnel have extensive publications within their areas of expertise and ongoing interactions with many
INIA PIs that are invaluable for the completion of the proposed studies. Drs. Roberto and Bajo will be dedicated
to the electrophysiology and biochemical studies, and Dr. Roberts to the behavioral studies.

Public health relevance
PROJECT NARRATIVE INIA-N investigators have shown that brain immune-related pathways are involved in excessive ethanol consumption and that pharmacological intervention with anti-inflammatory drugs reduces drinking. This project will examine the cellular and synaptic mechanisms of alcohol-induced immune responses in the brain that are hypothesized to contribute to excessive drinking. Therefore, the present studies have the potential to identify new therapeutic targets to reduce excessive drinking.